Contract Orientation and Kickoff Meeting (POP: 8/14/2019-9/13/2019)

This is the first phase in the IDIQ contracting process. RFPs for Task Orders can now be released to the pre-qualified pool of contractors.